Molecular ontology of drug tolerant persisters in HER2 positive breast cancer - Resubmission - 1

SUMMARY: “Targeted therapies” against “driver oncogenes” play key roles in the therapy of many tumors,
including breast cancers caused by amplification of the gene encoding the receptor tyrosine kinase HER2
(HER2+ BC). In metastatic HER2+ BC, however, resistance occurs even to combinations of anti-cancer
drugs, and preventing its emergence is essential for converting remissions to cures. “Drug-tolerant persisters”
(DTPs) survive exposure to tyrosine kinase inhibitors (TKIs) and other anti-neoplastics in a non-proliferative,
quiescent (dormant) state via reversible, non-genetic mechanisms. DTPs are implicated in resistance of
EGFRmut non-small cell lung cancer (NSCLC), BRAFmut melanoma, and other cancers, but a potential role in
in HER2+ BC had not been explored thoroughly. We found that HER2+ BC lines treated with HER2-TKIs
(lapatinib, tucatinib) give rise to two types of DTPs, which have luminal or mesenchymal transcriptomes. As
in other cell lines, a fraction of HER2+ BC cells transit stochastically through G0 after exiting mitosis, instead
of proceeding directly into G1. Remarkably, luminal DTPs arose uniquely from these transient G0 cells (“pre-
DTPs”), which also express a subset of DTP genes. HER2+ BCs are highly proliferative, yet like other tumors,
they also have significant numbers of G0 (Ki67-) cells, and our initial analyses of samples from TKI-treated
HER2+ BC patients comport with DTP generation from G0 cells. Thus, in contrast to current models, which
contend that the drug-tolerant, quiescent state is induced by TKIs and other targeted
therapies/chemotherapies, our data indicate that pre-DTPs might already be present in the drug-naïve
population.
We hypothesize that the chromatin of such transient, G0/pre-DTP cells has a globally distinct
organization that primes them to induce the complete DTP transcriptome and become drug-tolerant upon
TKI exposure. Whether this “G0 selection/induction” model applies to mesenchymal-like HER2+ DTPs, DTPs
induced by other agents, and/or more broadly to bona fide HER2 tumors remains unclear. Because DTPs
comprise a potential cellular reservoir for seeding stable resistance to HER2 TKIs and other
targeted/conventional therapies, delineating their ontogenetic mechanisms could reveal novel cancer
vulnerabilities and ultimately, new therapies. Our focus on the unique features of gene regulation in G0 cells
could also have implications for tumor dormancy. This proposal joins experts in epigenetics/chromosome
organization (SKOK) and cancer biology/cell signaling (NEEL) to address these timely, relevant questions
Specifically, we will: (1) Characterize chromatin architecture and gene regulation in HER2-TKI pre-DTPs and
DTPs from luminal-like HER2+ BC lines, (2) Test the hypothesis that HER2-TKI DTPs from mesenchymal
HER2+ BC lines also arise from G0-like pre-DTPs and have condensin II-organized chromatin, and (3) Test
the pathophysiological significance of lapatinib DTPs in in vivo models of HER2-TKI DTPs.

Public health relevance
NARRATIVE: Resistance to targeted therapies severely limits their clinical efficacy in metastatic malignancies. Increasing evidence points to DTPs as major reservoirs for enabling stable resistance to develop. Our work will clarify the ontogeny and relevance of DTPs in HER2+ BC.